Administrative Core

Core A: Administraton - The overall mission of the Administrative Core is to provide oversight, coordination, integration, global decision making, training, and leadership in coordinating the scientific, clinical, and financial aspects of this NTR Research Center. The Director for this Core is Thomas Wang, MD.PhD. He is also the Site Director at the University of Michigan, and will be intimately familiar with all aspects of standardization of the imaging protocols and clinical validation of fluorescent-labeled peptide, including proper function and calibration of the wide area endoscope and confocal microscope, concerns of the IRB and FDA, patient safety and logistical issues, and budget matters. Roy Soetikno, MD is the Core Co-Director at Stanford University, and will function as their Site Director. Kenneth Wang is also a Core Co-Director and is from the Mayo Clinic. He will be a representive on the NTR Steering Committee in addition to Dr. T Wang. The Directors of the Administrative Core will discuss the operations of the NTR Research Center at the regular Executive Committee meeting via teleconference on a bi-weekly basis. Implementation and follow up of action items will be performed by the Operations team, which includes 1) Don May, the NTR financial administrator at the University of Michigan, 2) Erin Shugard (University of Michigan), Christine Du (Stanford University), and Kelly Dunagan (Mayo Clinic), the CRAs at each respective site.